Core D: Dissemination and Outreach Core

PROJECT SUMMARY
The Dissemination and Outreach (D&O) Core is an essential component of the Prospective Genetic Risk
Evaluation and Assessment Study (PROGRESS) in Autism Center. Our multidisciplinary Center will
prospectively identify and partner with a cohort of families whose children are at identified genetic risk (IGR) for
autism. Parents will receive genetic screening results prior to any clinical indication of developmental delays or
differences, which creates opportunities for early interventions, however receiving this information also carries
ethical concerns for the well-being of the parents, especially in minoritized communities. The D&O Core will
accomplish the PROGRESS Center’s overarching goals of rapidly disseminating research findings to
stakeholders, supporting families, engaging and communicating with the autistic community, and training new
investigators, through four aims: Aim 1, Dissemination of PROGRESS Center Results, is imperative to inform
scientific exchange, clinical practice, affected communities, and downstream policy. We will use in-person and
online seminars and town halls, as well as the PROGRESS Center website, to share information with autistic
individuals, families, clinicians, educators, and scientists. Aim 2, Outreach and Support, will optimize
information and support for PROGRESS Cohort families as well as others impacted by IGR of autism through
individual and group family navigation sessions to help parents and infants gain access to early intervention
services. Aim 3, Translation and Exchange, will optimize bidirectional communication and collaboration
between the autism community stakeholders and PROGRESS investigators through a Community Advisory
Board to cultivate an authentic community-academic partnership that informs approaches to share results with
the communities that would most benefit from them, as well as provides new strategies to maximize the